The Role of Airway Epithelial Complement in Chronic Beryllium Disease

PROJECT SUMMARY/ABSTRACT
Beryllium (Be) is used in several industries and the US is the largest exporter of Be in the world. Despite
mitigation strategies, Be exposure at the workplace results in Be sensitization (BeS) and Chronic Beryllium
Disease (CBD). CBD is an important but understudied organ-specific immune-mediated disease characterized
by granulomatous lung inflammation, fibrosis, and death. Hence, CBD is a public health concern resulting in
the promulgation of new exposure standards recently. BeS develops in up to 20% of Be-exposed individuals
and progresses to CBD in 50-100% of these at-risk individuals. The goal of this study is to determine if
complement activation in nasal and bronchial epithelial cells perpetuates the immune response contributing to
the exposure-mediated immune disease, CBD. This project hypothesizes that nasal and bronchial epithelial
cells share common CBD-related and complement-related gene expression and activation, leading to
enhanced immune responses to Be-exposure in BeS and CBD. In Aim 1, the study will determine gene
expression profiling from paired nasal and bronchial brushings cells in CBD and BeS as compared to healthy
controls, primarily focused on complement genes and pathways. We will determine Be-related airway epithelial
cells transcription of paired nasal and bronchial brushings cells in BeS (n=16), CBD (n=16), and controls
(n=10). We aim to 1) investigate if gene expression profiling of nasal brushings is similar to that of bronchial
brushings, and to determine whether nasal brushing can be used as a non-invasive biomarker of the lower
airways in the study of CBD. 2) analyze gene expression levels of complement pathway gene expression. In
Aim 2, the study will validate the complement genes identified as key drivers of immune response to Be in
epithelial cells. We will use patient-autologous CD4+ T cells and bronchial epithelial cells grown at air-liquid
interface (ALI) co-culture models. Specifically, we will use the CRISPR-dCas9 system to target the expression
of candidate complement genes (knockdown and overexpression) in airway epithelial cells and determine the
impact of complement activation on CD4+ T cell Th1 responses to Be. At the completion of this project, the
proposal will enhance our understanding of the identificationcation of novel genes and regulatory pathways
associated with Be lung disease, launching an investigation of novel pathogenic mechanisms and setting the
stage to determining more rapid and non-invasive detection of CBD and BeS in future studies. Finally, this
study will provide a framework to investigate other granulomatous or exposure-related lung diseases, such as
hypersensitivity pneumonitis and sarcoidosis.

Public health relevance
PROJECT NARRATIVE Chronic beryllium disease (CBD) develops in up to 16% of Be-exposed workers and progresses to end-stage respiratory failure in one-third of these patients. Beryllium sensitization (BeS) is the precursor of CBD. This study will determine if complement activation in nasal and bronchial epithelial cells perpetuates the immune response contributing to the exposure-mediated immune disease, CBD.